Training in Health Services Research

Building on our success over the last five decades, our plans to train the next generation of
health services researchers builds on the recognition that science and context must continually
evolve so that new researchers are prepared to provide the evidence needed to inform future
decisions of organizations, practitioners, policy makers, communities, and patients to result in
better health. The Johns Hopkins pre-doctoral AHRQ NRSA training program aims to
prepare PhD-level health services researchers in three intersecting updated high priority areas:
1) Understanding how the Financing and Organization of Healthcare Services Affect
Efficiency, Quality, and Equity of Care addresses how our healthcare system’s public and
private financing mechanisms and organizational structure affect health; 2) Advancing Patient
Safety, Quality and Patient-Centered Outcomes addresses traditional and evolving areas
with the rise in person-centered care, value based purchasing, health information technology
and emerging data sources, and the importance of diagnostic excellence; and 3) Promoting
Health Equity for Historically Marginalized and Vulnerable Populations is designed to
improve our focus on populations underserved by lack of access to quality health and social
services and vulnerable groups with complex care needs that often lead to poorer quality of care
and outcomes. Our pre-doctoral training builds on a common core of course work emphasizing
rigorous skills including study design, statistical analysis, measurement, data/health information
technology use, evaluation, and policy analysis. We base our training on a detailed set of core
competencies and learning objectives developed in accordance with the 2005 AHRQ sponsored
national “HSR core competencies” conference hosted by our Department and updated in 2012
and 2018. To address transformational factors and emerging problems in the U.S. health care
system, we will increase our emphasis on changing financing and systems, health information
technology, and promoting health equity. Trainees will gain exposure and research experience
through coursework, seminars, individual involvement in faculty research, and practica. AHRQ
will support three years of training for 3-4 new pre-doctoral students per year. Our program
offers personalized small group and one-on-one support and guidance by experienced mentors
to ensure a coordinated, successful training program experience for each trainee. Our training
program is well integrated with Department, School and University active research programs
and benefits from a large and diverse faculty with great breadth and depth in our priority areas
and the extensive opportunities in research and policy in the Washington, DC area.

Public health relevance
Public Health Relevance The U.S. health system continues to experience multiple pressures and dramatic transformations in the organization and delivery of care. There is great need for well-trained researchers to help assure the quality and safety of care that is delivered, to determine how it should be organized and paid for, and to assure equitable access and outcomes. The proposed training program at Johns Hopkins will prepare multidisciplinary PhD researchers to meet these needs.